Pilot Project 1: Creating Bridges to Reproductive Health Care for Rural Adolescent and Young Adult Cancer Survivors

PROJECT SUMMARY/ ABSTRACT – PILOT PROJECT
Reproductive health care in cancer patients is an unmet need in Imperial County, a medically underserved,
rural region of the Cancer Research and Education to Advance HealTh Equity (CREATE) Partnership’s
catchment area with a predominantly Hispanic population. Reproductive health is a major issue for adolescent
and young adult (AYA) cancer survivors because they can experience higher risks of infertility, adverse
pregnancy outcomes, and unmet informational needs. Reproductive health care effectively reduces risks, but
uptake is low because there are no scalable interventions to support the implementation of routine reproductive
health care in underserved, geographically remote communities. Guided by the Cancer Survivorship Care
Quality Framework, this pilot proposal seeks to adapt and pilot test a multi-component intervention to improve
reproductive health care uptake by female AYA cancer survivors. The intervention has three components
derived from our prior work: 1) a reproductive risk summary (RS) and survivorship care plan on reproductive
health (SCP-R), 2) navigation, and 3) telehealth reproductive consults. In Aim 1, we will adapt the RS and
SCP-R in English and Spanish to be responsive to the cultural, health literacy, and socio-ecological needs of
Latina AYA survivors through focus groups with AYA survivors and parents/guardians, and semi-structured
interviews with healthcare providers. We will also systematically evaluate barriers and facilitators to
reproductive health care in Imperial County and examine how to fit the multi-component intervention to this
setting, through focus groups with survivors and parents/guardians and interviews with healthcare providers
and clinic staff. In Aim 2, we will conduct feasibility testing of the multicomponent intervention in a single arm
pilot hybrid type 1 trial (evaluating effectiveness and observing implementation). The primary outcome is
engagement in reproductive health care by 15 newly diagnosed and 15 post-treatment AYA survivors.
Secondarily, we will qualitatively assess effectiveness, fit and implementation outcomes with AYA survivors,
healthcare providers and health clinic staff. The proposal directly targets a critical health disparity faced by
female AYA survivors in our catchment area and need for partnership between rural community health
professionals and urban specialists to deliver quality reproductive survivorship care. We will generate a novel,
scalable intervention and preliminary data to support a future multi-site trial on intervention effectiveness in
increasing reproductive care in rural, medically underserved oncology settings. The partnership between
SDSU, CRCD and UCSD researchers will be strengthened with collaborative learning, community
engagement, and increased capacity of trainees to support future cancer research in Imperial County.